Project 4: Investigation of Clinical, Blood, and Neuroimaging Biomarkers as Predictors of Independent Walking Post-stroke

Prediction of walking recovery after stroke can inform patient-centered care and support discharge
planning. The accuracy of current prediction models is limited, however, due in part to small study designs
and narrow predictors assessed. We propose a comprehensive evaluation of a novel combination of
biomarkers to improve prediction of walking recovery and guide rehabilitation efforts after stroke. These
include acute structural brain network disruption (utilizing MRI); blood biomarker levels (e.g., brain-derived
neurotrophic factor and vascular endothelial growth factor); and clinical assessments of strength and
mobility. The long-term goal is to develop a competitively funded research program to optimize gait
rehabilitation strategies based on neural substrates of walking impairment and recovery after neurologic
injury. The overall objectives in this application are to assess study protocol feasibility and investigate
relationships between select biomarkers and walking recovery to provide strong justification for a larger
study on predictors of independent walking after stroke. The proposed objectives will be pursued through
the following specific aims: 1) Assess feasibility of a larger study and develop methods for telehealth data
collection; 2) Establish baseline levels of biomarkers (clinical, neuroimaging, blood) and average change
over time; and 3) Elucidate relationships between baseline levels of biomarkers and walking gains across
time in persons after stroke. A longitudinal, observational study design will be utilized for this study. Thirty-five
persons with acute (<3 days) stroke will be recruited from the local medical center. Select inclusion
criteria include presence of new lower limb weakness and assistance for walking; select exclusion criteria
include cerebellar stroke and contraindications to MRI. Subjects will undergo clinical evaluation within 3
days, 1, 4, 9, 12, and 26 weeks after the initial onset of stroke symptoms. MRI scans will occur 5-12 days
and 12 weeks post-stroke, and blood draws 72 hours, 1 week, and 12 weeks post-stroke. To assess
feasibility we will examine study processes, recruitment, resources, study management, and scientific
assessment. To examine the role of acute clinical, neuroimaging, and physiological measures in predicting
walking recovery, we will examine relationships between these measures and walking outcome at 12-
weeks post-stroke. This study employs an innovative approach to investigate predictors of walking recovery
after stroke. The proposed research is significant because it is expected to provide strong scientific support
for future clinical trials designed to target therapies based on predicted functional potential. Ultimately, such
knowledge has the potential of enhancing mobility gains and patient independence following stroke.